Duke University Medical Center (DUMC) Pelvic Floor Disorders Network (PFDN) Clinical Site

ABSTRACT
The Pelvic Floor Disorders Network (PFDN) has provided the framework for landmark clinical trials that utilize
rigorous methodology to change clinical practice. The Duke University Medical Center (DUMC) PFDN
Clinical Site has been a significant and consistent contributor since 2007. We are excited to offer our
dedicated faculty, experienced research team, and established track-record of high patient recruitment with this
re-application to the PFDN. DUMC has a rich tradition of excellence in clinical care, training and research in
pelvic floor disorders, offering detailed evaluation and treatment in a high-volume, multidisciplinary setting with
broad institutional resources, and serving as a tertiary southeastern US referral center. Our eight fellowship-
trained urogynecology investigators have expertise in both surgical and non-surgical management of the full
spectrum of pelvic floor disorders including urinary urgency/frequency, urinary incontinence (UI), fecal
incontinence (FI), and pelvic organ prolapse (POP). Last year, our Urogynecology Division cared for 3165 new
patients, performed 191 surgical procedures for UI and 377 for POP. This is in addition to 474 non-surgical
procedures (including bulking injection, bladder Botox, and percutaneous tibial nerve stimulation) for UI. The
Urogynecology Division is a hub of multidisciplinary collaboration including urology, colorectal surgery,
gastroenterology, radiology, physical therapy, and multiple basic research laboratories across our campus.
DUMC provides comprehensive diagnostic evaluation including multi-channel urodynamic testing, video
urodynamics, cystoscopy, defecography, static and dynamic MRI, as well as and endoanal ultrasound. We
have expertise in study design, recruitment, retention, adverse event reporting, and data analysis. We have
unique and substantial expertise in translational sciences and prediction modeling that we aim to leverage in
innovative translational aims embedded in PFDN clinical trials. Our clinical patient population is 72% White,
19% African American, 0.4% Latina, 0.3% Asian, and 0.01% American Indian, from suburban and rural
communities with stable care and follow-up patterns. We recognize that our clinical population is skewed as
Durham County statistics report that our local community is 50% White, 37% African American, 13% Latina,
4% Asian, and 4% American Indian. Thus, in the current cycle we will actively engage with new institutional
resources that provide bilingual coordinators and community-based engagement for research. The long-term
objective of the DUMC PFDN Clinical Site is to improve the evidence-based clinical care of women with pelvic
floor disorders. To accomplish this objective, we propose to provide meaningful scientific contributions to the
PFDN by collaborating with other sites and the data coordinating center, implementing all approved protocols
in a manner that maximizes faculty engagement and participant recruitment and retention, and involving
collaborators with a range of clinical, basic science, and methodological expertise, when appropriate.

Public health relevance
PROJECT NARRATIVE Symptomatic pelvic floor disorders occur in 25% of women in the United States. Given their high prevalence, impact on quality of life, and substantial economic costs, well-designed and well-executed clinical trials focused on prevention or evidence-based treatments are desperately needed. The Duke University Medical Center is committed to actively participating in innovative multicenter trials to achieve this goal.